The Role of Osteopontin-OGDHL Axis in HFpEF

ABSTRACT
The goal of this minority supplement is to train and mentor an underrepresented Jamaican young
lady during her transition from a medically-trained doctor to a physician scientist. Dr. Williams is
an ambitious post-doctoral candidate who performed research via the Health Disparities &
Cultural Identities research lab at Florida International University (FIU) assessing HPV risk. She
was also a recipient of the South East Alliance for Graduate Education and the Professoriate
(SEAGEP) award for undergraduate research in 2010. During this period, she assisted with the
development of laboratory protocols for the Biomaterials laboratory at FIU. Dr. Williams was
introduced to our team by another current Diversity Supplement awardee (Dr Julian Dunkley).
Williams learnt about our NIH-funded HFpEF project and became very interested in training in
basic and translation research. If granted, this postdoctoral supplement combined with the
excellent environment, support, and extraordinary resources at the Interdisciplinary Stem Cell
Institute and the University of Miami Miller School of Medicine will provide Dr. Williams with the
tools and methodology necessary to become an independent physician scientist in the field of
cardiovascular research where female Jamaican scientists are rare. This proposal is the logical
extension of the parent grant entitled “Role of OPN-OGDHL Axis in HFpEF” (1R01HL140468)
and is performed within the scope of the original project. As such, we will characterize the blood
pressure and heart rhythm in the new HFpEF cardio-renal mouse model we recently
characterized by implanting a telemetry device. We will assess the arrhythmia in the Alport mouse
± beta agonist/antagonists. The mice used will be from the three different genetic strains that we
developed. This new approach barely modifies the proposed strategy and models, which keeps
these additional experiments within the scope of the parent grant. The proposed experiments are
anticipated to finish within the next 14 months.

Public health relevance
NARRATIVE Due in part to the complex heterogeneity of the disease phenotypes as well as an absence of mechanistic insights into disease development and progression, clinical trials targeting heart failure with preserved ejection fraction (HFpEF) so far have failed and there is no etiological therapy for HFpEF. The current proposal will allow us to present a new mouse model for HFpEF and understand new mechanisms underlying the development of this syndrome.